ZFIN: The Zebrafish Model Organism Database

Discovering the functions of the tens of thousands of genes in the human genome is a required step for
understanding human biology and disease. Genetic model organisms, including zebrafish, play a critical role in
this discovery process, because genetic analysis can connect gene sequence and function. Model organism
databases, like ZFIN, provide tools required to make this connection.
The zebrafish has emerged as a premier organism to study vertebrate biology. Powerful techniques allow
rapid efficient generation and recovery of mutations affecting genes that orchestrate developmental patterning,
organogenesis, physiology, and behavior. It is easy to study gene function by generating transgenic zebrafish,
by knocking down gene function with morpholino antisense oligonucleotides, or by altering gene function by
genome editing. The genome has been sequenced and about 50% of the protein coding genes have been
mutated by targeted gene knockout technology. Large-scale projects are underway or planned that will
produce functional data about almost all the genes and sequence-based functional elements in the genome.
Multiple mutations and gene knockdowns can be combined in the same individual to study gene modifiers and
other genetic interactions. The functions of most of these genes are conserved among vertebrate groups.
Thus, analysis of zebrafish mutations provides insights into gene functions in other vertebrates, including
humans.
The long term goals for ZFIN are a) to be the community database resource for the laboratory use of
zebrafish, b) to develop and support integrated zebrafish genetic, genomic, developmental, and physiological
information, c) to maintain the definitive reference data sets of zebrafish research information, d) to link this
information extensively to corresponding data in other model organism and human databases, e) to facilitate
the use of zebrafish as a model for human biology, and f) to help serve the broad needs of the biomedical
research community.
This project will continue and expand curation of zebrafish research data, develop expanded support for
zebrafish models of human disease, expand and integrate links to other databases, and maintain and update
the zebrafish reference genome. This work will provide a powerful means for researchers to associate gene
sequence and function, thus facilitating studies of human gene function and disease as well as cross-species
analyses of genome organization and evolution.

Public health relevance
ZFIN analyzes and curates zebrafish research data, provides support for zebrafish models of human disease, integrates links to data from other databases, and maintains and updates the zebrafish reference genome. The long term goals for ZFIN are a) to be the community database resource for the laboratory use of zebrafish, b) to develop and support integrated zebrafish genetic, genomic, developmental, and physiological information, c) to maintain the definitive reference data sets of zebrafish research information, d) to link this information extensively to corresponding data in other model organism and human databases, e) to facilitate the use of zebrafish as a model for human biology, and f) to help serve the broad needs of the biomedical research community.